Unraveling the Telomere Black Box: A New Single-Molecule Approach to Define the Telomere Chromatin Landscape and its Functional Mechanisms

Summary
Telomeres are end-capping protein-DNA structures at the ends of the linear human chromosomes. They protect
our genome integrity by sacrificing their repetitive DNA when the ends of the chromosome suffer attrition during
DNA replication and camouflaging the chromosome ends from wrong DNA breakage recognition. Deregulation
or loss of telomeres results in genome instability and leads to human diseases such as cancer and premature
aging. The telomere's repetitive DNA nature provides a unique challenge in understanding their biological
processes. This is because telomeric proteins can bind the repetitive telomeric DNA in many ways, leading to
complexity and diversity in the telomere chromatin landscape; there are functional consequences to how
telomeric proteins decorate a telomere chromatin landscape because these proteins directly participate in
telomere protection and length maintenance. Thus, our understanding of telomeres is like a "black box". We
know the inputs (proteins and lncRNA) and outputs (telomere length and end-protection) and understand how
variations of inputs transform to output changes. However, we do not know what is going on inside the "black
box". This "black box" is the telomere chromatin landscape.
Characterizing the telomere chromatin landscape has been an insurmountable task for the telomere research
field for decades. The ChIP-Seq technique has revolutionized chromosome biology research, but repetitive
genomic regions such as the telomeres are left behind. This is because the relative positional information of the
protein-DNA interactions is lost upon the fragmentation step in ChIP-Seq, preventing us from reconstructing the
chromatin landscape of interest. This proposal seeks to innovate new tools to map the human telomere chromatin
landscape at a single-telomere level. These tools will then use to study how the telomere chromatin landscape
regulates telomere end-protection and length maintenance. First, I will establish the proof-of-concept
experiments for using non-native DNA methylation to mark protein-DNA interactions at the repetitive telomeric
DNA regions and reconstruct the chromatin landscapes with structural details. These tools will then be used to
tackle two major research areas: (1) What is the human telomere chromatin landscape and how it changes
across the cell cycle from a resting protective state to one permissive to DNA replication progression. (2) How
changes in the human telomere chromatin landscape drive telomere length maintenance.
This proposal thus consists of both technological and conceptual innovations. The new tools will provide a
new way to investigate chromosome biology at repetitive genomic DNA regions; thus, its impact extends beyond
the telomeres. We will get an unprecedented first look into the telomere chromatin landscape. Hence, this
proposal has enormous potential to open multiple new research directions in telomere biology; a paradigm shift
in our telomere knowledge is expected. Because of the biomedical importance of telomeres, the outcome of this
proposal can provide novel avenues to tackle telomere-related human diseases.

Public health relevance
Narrative Telomeres cap the ends of our linear chromosomes to protect our genome integrity; thus, their loss or deregulation often leads to cancer or premature aging human diseases. While we understand the inputs and outputs in telomere processes, we do not know what is going on inside the telomere “black box” - its chromatin landscape. This proposal describes an innovative methodology using single-molecule DNA sequencing and imaging technology to explore the telomere chromatin landscape and understand how it can regulate the telomere functions.